Youth-PRIDES: Implementing integrated, mHealth care for adolescent depressionwithin primary care clinics of Mozambique

Globally, mental disorders are the largest contributor to burden of disease in adolescents, yet the vast majority
of youth worldwide do not have access to treatment. Mental health services integrated within primary care and
delivered by non-specialists (i.e., task-shifting) offer an efficient and sustainable method to close the
adolescent mental health treatment gap. However, research is needed to determine how to effectively
implement task-shifted, integrated adolescent mental health care, particularly in low-resource settings. The
goal of this K01 Award is to expand the candidate’s expertise and prepare her to conduct independent
research on the implementation and dissemination of evidence-based practices (EBPs) for managing
adolescent mental disorders in low-resource settings. Through a combination of coursework and seminars,
clinical observation, scientific conferences, collaborative publications, and mentorship from experts in global
adolescent mental health and global mental health implementation research, the candidate will develop
competency in 1) the development, expression, and treatment of global adolescent mental disorders; 2) mixed-
methods, community-based assessment of parameters relevant to contextual adaptation and implementation
of adolescent mental health interventions; and 3) conducting hybrid effectiveness-implementation trials of EBP
for sustainably managing adolescent mental disorders in low-resource settings.
The candidate will apply knowledge and skills gained through training activities to conduct a multi-
phase study in Mozambique, the fourth poorest country in the world. Leveraging an existing partnership with
the Ministry of Health and research infrastructure developed through the PRIDES study to evaluate pathways
for scaling-up adult mental health services (U19MH113203), the candidate aims to design and evaluate a
strategy to implement screening and treatment for adolescent depression integrated within primary care clinics.
Community-based, mixed-methods research will identify cultural and contextual barriers and facilitators to
implementing integrated adolescent depression services (Aim 1). This data will inform contextual adaptation of
group interpersonal therapy for adolescents (IPT-A), an EBP for adolescent depression. It will also be used to
develop a strategy to implement depression screening and IPT-A in which non-specialist providers are guided
by mobile health (mHealth) tools that promote treatment fidelity (Aim 2). Patient and implementation outcomes
of the depression management strategy will be evaluated in a pilot, cluster-randomized trial (Aim 3) and used
to develop an R01 proposal for a hybrid effectiveness-implementation trial to assess scale-up of integrated
adolescent depression care throughout Mozambique. Together, the training, research, and research-policy
partnership in the proposed award will support the development of an innovative model for engaging with local
stakeholders to adapt and implement mHealth, task-shifted EBPs for managing adolescent mental disorders in
low-resource settings, contributing to the NIMH’s goal of maximizing public health impact of research.

Public health relevance
Mental disorders are the leading cause of disability among adolescents worldwide, but only a very small minority, mostly in high-resource settings, have access to mental health care. The proposed K01 supports the candidate’s transition to a research career generating novel models for effectively implementing adolescent mental health services in low-resource settings. The resulting knowledge can inform both public health policy and intervention strategies to reduce the global burden of adolescent mental disorders.